A novel clinically-relevant mouse model of chronic overlapping pain conditions for screening analgesics

Chronic overlapping pain conditions (COPCs) affect over 100 million people, yet remain ineffectively treated due,
in large part, to lack of valid animal models with translational relevance. In response to FOA PAR-18-763, this
proposal seeks to develop a new mouse model of COPCs with improved external validity to facilitate discovery
of neurotherapeutics with analgesic and anti-inflammatory effects. Our model will incorporate key genetic and
environmental factors known to contribute to the etiology of COPCs through enhancing catacholaminergic tone.
An estimated 66% of patients with COPCs such as fibromyalgia have functional variants in the gene encoding
catechol-O-methyltransferase (COMT; a ubiquitously expressed enzyme that metabolizes catecholamines), that
result in low COMT activity. The effect of COMT genotype on pain is modified by stress and injury. For example,
individuals with the ‘low activity’ COMT genotype report enhanced pain following stressful events (eg, motor
vehicle collision and psychological strain) and injurious surgical procedures (eg, molar extraction and
mastectomy). Low COMT, stress, and injury can produce pain by increasing the production of pro-inflammatory
cytokines that sensitize nociceptors. Previously, our lab employed a pharmacologic approach to study
mechanisms and targets driving COMT-dependent pain, yet this approach does not adequately mimic the
complex clinical etiology of COPCs. Thus, the objective of this proposal is to develop and validate a novel
mouse model of COPCS in which genetically predisposed COMT+/- mice undergo stressful and injurious events.
Our central hypothesis is that COMT+/- mice undergoing transient stressful and injurious events will develop
chronic pain at multiple body sites and increased levels of clinically-relevant cytokine biomarkers that will be
reduced by existing FDA-approved analgesics. Preliminary data show that COMT+/- mice, which exhibit normal
baseline pain behavior, undergoing swim stress and molar extraction surgery develop exaggerated long-lasting
pain at multiple body sites (hindpaw, back, and abdomen). Further, COMT+/- mice undergoing swim stress and
molar extraction exhibit increased nociceptor activity. The studies proposed herein will extend this work. During
the 1.5-year R61 phase, we will establish the magnitude and duration of pain at several body sites, sensitization
of primary afferent nociceptors innervating those body sites, and pain-related depressive- and anxiety-like
behaviors in our COPC mouse model. Upon meeting the ‘go milestones’: COMT+/- vs WT mice undergoing
stress+injury exhibit significant increases (effect size >3) in 1) mechanical pain at multiple body sites and 2)
nociceptor activity, we will move to the R33 phase. During the 1.5-year R33 phase, we will evaluate clinically-
relevant cytokine biomarkers to determine construct validity and clinically-used analgesics to determine
predictive validity of our model. If successful, we will develop a novel mouse model of COPCS with improved
validity that will have a significant impact on effective discovery of analgesics with translational relevance.

Public health relevance
PROJECT NARRATIVE Common chronic overlapping pain syndromes (COPCs), such as fibromyalgia and temporomandibular disorder, constitute one of our nation’s most significant healthcare problems, affecting nearly one in every three Americans. Despite their high prevalence, COPCs remain ineffectively treated, in large part, due to lack of valid animal models with translational relevance for discovery of safe effective therapies. Thus, the objective of this proposal is to develop and validate a novel mouse model of COPCS in which genetically predisposed mice undergo stressful and injurious events resulting in clinically-relevant behavioral and molecular phenotypes for in vivo screening of analgesic therapeutics.